Scarring and Arrhythmia in Infarcted Aged Hearts: Role of Senescent Fibroblasts

Aging is associated with more than a 10-fold increase in the incidence of sudden cardiac death (SCD). Cellular
senescence is a stress response that is characterized by an irreversible loss of proliferative capacity,
accompanied by a complex senescence-associated secretory phenotype (SASP) that can have profound
effects on neighboring cells in the tissue. Our research plan is based on the following main premises. First, that
fibrosis is a consequence of heart injury (myocardial infarction) by being part of the natural wound healing
response, and that inflammatory processes in the scar may predispose the heart to arrhythmias. Second, that
cellular senescence of cardiac fibroblasts (CFs) plays an important role in post-MI wound healing. The
overarching hypothesis of our proposal is that senescence is an important component of wound healing in the
heart. Specifically, we postulate that in the aging human heart with a healed MI, the interplay between aging
cardiomyocytes (CMs) that have a lower threshold for arrhythmogenic activity, and the a modified senescence
response observed in the aging heart may lead to arrhythmogenesis. Furthermore, we hypothesize that aging
also impacts the senescence of cardiac fibroblasts (CFs) by either affecting the kinetics of the senescence
response, the intrinsic properties of the senescent cells, or their clearance by the immune system. This multi-PI
proposal brings together several investigators with very different expertise to investigate mechanisms of SCD
in the aging heart, using a novel age-appropriate large animal model (rabbit), CFs-specific genetically modified
mice, and engineered 3D microtissues of CMs and CFs where their interactions can be studied in vitro. In Aim
1 the Koren group will investigate the infarct healing process in the aging rabbit heart, as compared to the
young heart, and correlate the arrhythmogenesis with molecular and cellular analysis of CMs and CFs and
myofibroblasts derived from the IBZ and infarct zone (IZ) as compared to the remote zone (RZ). In Aim 2 the
Sedivy group will use mouse models to focus on the role CFs senescence in this process. Senescence will be
manipulated in vivo using genetic and pharmacologic approaches, CFs will be cultured and investigated in vitro.
Optical mapping of hearts ex vivo will be used to study arrhythmogenesis. In Aim 3 the Mende and Choi
groups will study the effect of senescent CFs on excitation, conduction and calcium handling in biomimetic
cardiac microtissues, in which CMs and senescent CFs can interact via direct cell-cell contact. In summary, we
envision that by understanding the aging mechanisms that control cellular senescence we will be able to
reduce fibrosis and the incidence of SCD.

Public health relevance
PROJECT NARRATIVE Sudden cardiac death (SCD) causes 20% of deaths in industrialized countries, and aging is associated with a greater than ten-fold increase in the incidence of SCD. This proposal will investigate the innovative hypothesis that cellular senescence of cardiac fibroblasts is causally involved with delayed infarct healing of the aging heart, predisposing it to arrhythmogenesis which can lead to SCD. We envision that pharmacological manipulation of cellular senescence could lead to better management of heart healing and hence alleviate subsequent progression to SCD.